Balance tele-rehabilitation with wearable technology for older adults with Parkinson disease

Abstract. Maximizing independent function during the progressive decline of balance and mobility in older
adults with chronic diseases, such as Parkinson's disease (PD), is a unique challenge for rehabilitation.
Balance training to reduce fall risk is a critical feature of rehabilitation for older adults, especially those with PD.
However, the recent COVID-19 pandemic has uncovered serious weaknesses in safely and effectively
delivering balance rehabilitation in people's homes. In fact, balance rehabilitation, for the most part, has been
deferred during the pandemic due to inability of tele-rehabilitation to remotely assess balance skills, exercise
task performance, or transfer of balance skills into daily life. We hypothesize that using objective measures for
balance assessment remotely will improve outcomes and that telerehabilitation is feasible using state-of-the-
art, evidence-based balance rehabilitation.
In 80 people with PD, we will use state-of-the-art wearable sensors to objectively measure balance in the home
and in daily life passive monitoring. In Aim I, we will determine if a virtual, instrumented balance assessment
using wearable sensors can predict performance on our gold standard, clinical in-person balance assessment
(Mini-BESTest). In Aim II, we will determine the feasibility and efficacy of a balance-focused tele-rehabilitation.
For this Aim people will be randomized into either unsupervised home exercises (standard of care) or 2)
physical therapist-supervised, balance tele-rehabilitation. In Aim III, we will explore if improvements after tele-
rehabilitation transfer to daily life mobility, measured with 7 days of passive monitoring. This project will
determine the feasibility and efficacy of using wearable sensor-based measures of balance and gait to improve
virtual assessment of balance in people with PD. Moreover, we will explore how tele-rehabilitation improves
balance and if the improvement translates to daily mobility. This outcome of this project will help develop a
more effective home-based balance and rehabilitation assessment and treatment that can be used in any older
adults with balance impairments.

Public health relevance
Narrative Maximizing independent function during the progressive decline of balance and mobility in older adults with chronic diseases, such as Parkinson's disease (PD), is a unique challenge for rehabilitation. Tele-rehabilitation for balance disorders is relatively unexplored and may be beneficial to older adults who cannot attend in-person rehabilitation. In this project, we will test 80 people with PD to: 1) determine if using wearable sensors at home can improve objective assessment of balance and 2) investigate if balance-focused tele-rehabilitation can improve balance.